Neuroscience Scholars Program (NSP): Preparing the Next Generation of Neuroscience Leaders

ABSTRACT
The path forward to a more diversified neuroscience research workforce is one that addresses persistent
challenges and emerging opportunities in a fundamentally changed, and continuously changing, professional
environment. Challenges to the status quo are happening at the societal level, and increased digitization offers
new opportunities to engage and encourage a diverse workforce to thrive in neuroscience and related fields.
Building on the assets and expressed needs of neuroscience trainees, the Society for Neuroscience (SfN) will
carry out a five-year continuation of the Neuroscience Scholars Program (NSP) to foster retention,
persistence, and career success of graduate students and postdoctoral fellows from diverse backgrounds,
including from groups underrepresented in the biomedical and behavioral sciences. NSP’s extensive program
experience and recent external evaluations show a timely opportunity for the next program cycle to focus on
two overarching themes to meet needs of underrepresented neuroscience researchers (UNRs) in this ever-
changing world: (a) to support UNRs as agile and nimble leaders, with resources to navigate with greater
confidence, empowerment, and leadership in their professional environments, rather than simply “surviving” or
adapting, and (b) to foster a sense of belonging for UNRs in a global community of NSP participants,
alumni, and neuroscience leaders from multiple institutions that reinforces and supports thriving in the
neuroscience field. To address these themes over the five-year project period, Aim 1 supports the retention of
UNRs by providing at least 80 NSP Fellows with intensive in-person and online networking, mentoring, skills
development, and enrichment funds for research experiences. Aim 2 supports broader persistence efforts by
providing approximately 350 NSP Associates with career-building activities through online professional
development programming supplemented by targeted in-person experiences. Aim 3 supports the continued
career trajectory and long-term professional success of more than 1,200 NSP Alumni as leaders and mentors
in the NSP and broader neuroscience community. The primary delivery methods of the program will be new
courses for skills development including a focus on agile leadership and management skills, an update of
NSP’s existing library of courses, ongoing facilitated access to hands-on research experiences, and an
expanded mentoring program that includes a peer mentoring system. SfN anticipates this approach will
effectively facilitate NSP Fellows and Associates to gain a greater sense of identity as neuroscientists, and
along with Alumni, to experience greater confidence in their professional leadership abilities, facilitating
increased retention, persistence, and career success of UNRs. In this vein, NSP will contribute to a more
diverse research workforce that seeks answers to complex research questions relevant to diverse groups in
the general population and translates scientific findings into clinically significant and culturally appropriate
interventions that advance neuroscience and related fields.

Public health relevance
PROJECT NARRATIVE By supporting diverse neuroscientists at multiple career stages, the Neuroscience Scholars Program (NSP) fosters and grows a diverse neuroscience workforce that will efficiently address a breadth of difficult research questions and adopt approaches that may not be envisioned by groups with more homogeneous backgrounds and training. Such a diverse, well-trained neuroscience workforce is instrumental to making new discoveries about how the brain works and to finding innovative ways to prevent and treat neurological illnesses and disorders that account for a greater burden than any other group of diseases (Kaji, 2019). Diversity in the neuroscience workforce also ensures that research discoveries apply to a broader spectrum of the U.S. population; involving researchers from underrepresented groups increases attention to and research on health disparities and otherwise-neglected issues specific to women’s health and those of diverse populations (Ovbiagele, 2023).